3D Image Analysis Software for Breast Reconstruction Surgical Planning, Outcome Assessment & Clinical Consultation

Abstract
Breast cancer is the second leading cause of cancer death in American women. Breast reconstruction
surgery is an important component of the breast cancer treatment process, that is used to rebuild a breast form
that has been removed due to cancer surgery. It is integral to improving the cancer patient's health-related quality
of life. However, planning and evaluation of the surgery are done subjectively, and the result is not always
aesthetically satisfactory.
Standards for breast reconstruction have evolved over the past two decades, and patients and surgeons
alike expect natural, symmetrical -looking surgical outcomes. Surgeons rely on their personal experience and
on subjective visual assessment skills to achieve these results. Similarly, aesthetic outcome assessment
methods, following surgery, are rather subjective, and are based on observer evaluation of physical changes in
breast morphology and symmetry. With recent developments in three-dimensional (3D) imaging, there is now
an opportunity to develop software that permit use of breast morphometry and computerized simulations for
treatment planning, clinical consultation, and objective assessment of postoperative results. Currently, there is
no stand-alone, imaging-device independent software for a surgeon to automate measurements for objectively
formulating a surgical plan or generate realistic simulations of breast shape.
To address this challenge, we propose the development of software for quantitative assessment of breast
shape. 3D imaging has been validated for the clinical assessment of breast aesthetics but has seen limited use
for simulation and surgical planning due to the exorbitant costs (~$100-300K) of imaging equipment and lack of
appropriate image analysis tools. Low-cost (~8K), portable hand-held 3D scanners are now available, but
software for enabling breast morphometric analysis for surgical planning is lacking. In this Phase I STTR study,
Soft Imaging, LLC is collaborating with the University of Houston (UH) and The University of Texas MD Anderson
Cancer Center to develop 3D image analysis software that will utilize innovative and novel 3D image analysis
algorithms for enabling (1) automated approaches for breast morphometry and surgical planning and (2) employ
a parametric modeling approach based on 3D spherical harmonics (SPHARM) to model breast shape, to provide
realistic simulations for visualization during clinical consultations. This will help breast cancer patients make
informed decisions about their breast reconstruction treatment choices, calibrate her expectations, and be more
comfortable with her treatment choices.
At the completion of this Phase I feasibility study, a future Phase II project, will develop a prototype for
clinical testing at multiple sites, followed by Phase III commercialization. Applications would improve breast
cancer care in several ways, such as; surgical planning, enabling personalized simulations of surgical outcomes,
surgical education, and planning of comfortable postoperative garments (bras) for use during surgical recovery.

Public health relevance
Public Narrative Potential benefits for women undergoing breast reconstruction after mastectomy include improved body image, self-esteem, well-being, and an overall improvement in quality of life. A major step towards maximizing the benefits of breast reconstruction is to provide quantitative tools to assist surgeons with clinical consultation, preoperative surgical planning, and outcome assessment. This Phase I STTR study will develop software that would aid the surgeon in quantifying and interpreting 3D breast data in a meaningful and clinically relevant fashion and also serve as a tool to elicit patient preferences during clinical consultations via parameterized simulations of breast shape.